Whole-of-Community Systems Intervention for Youth Population Physical Activity

The underlying conditions where youth live are associated with population health outcomes, with rural
communities facing under-studied challenges. Youth physical activity (PA), a key risk factor linked to later
cancer occurrence, is an outcome of community conditions. The proposed work will address a critical public
health need by evaluating the impact of a whole-of-community multi-level adaptive systems intervention
on implementation of community change and youth population PA. Our intervention, Wellscapes, is based on a
hierarchical patch dynamics paradigm, given that communities are “wellness landscapes” of spatially
heterogeneous geographic areas, characterized by a patchwork of interacting organization and activity
settings. The intervention will establish a multi-level system infrastructure (Community Hub, Organization
Wellness Teams, Activity Setting/Leaders) and provide training and support for population health quality
improvement cycle processes targeting two evidence-based practices (EBPs): (1) stacking time segments of
PA episodes within an organization’s daily routine, and (2) improving the quality of PA episodes (% time in
PA). Our omnibus hypothesis is that intervention communities (plus organizations and leaders nested within)
will have synergy and capacity to implement EBPs, adapting to continuously changing local system drivers to
create a whole-of-community ecosystem of diverse and equitable youth PA opportunities. Building on local
health department partnerships, we will conduct a two-wave staggered-start community randomized trial with
four volunteer rural communities (each having nested school, after-school, scouting/4-H club, youth sport
organizations) randomly assigned to intervention or standard public health practice. For baseline and
intervention years, one day per month in the fall (3 days) and spring (3 days), organization activity settings
(e.g., classrooms, teams) that house 480 children in 3rd through 6th grades will be assessed, resulting in
observed community condition data, PA accelerometer data, and setting reach data (children % attendance by
gender, ethnicity, free/reduced lunch status, and grade). We will also obtain estimates of population level PA
with the use of the calibrated Youth Activity Profile, as well as community system qualitative data. The specific
aims are to: (1) Determine the impact of the intervention on multi-level community system outcomes; and (2)
Determine the implementation system drivers of multi-level youth population PA. We will use “big data” multi-
level modeling methods for this effectiveness-implementation hybrid design, because there is a dual focus on
testing an implementation strategy while simultaneously evaluating youth population PA impact. The research
is significant because it evaluates a method for improving population health, theory-based systems, and
behavior change processes in low-resource rural communities. The proposed research is novel because the
adaptive patch dynamics approach builds capacity for both equitable collaboration and EBPs implementation
across multiple local systems that are individually and collectively, dynamic and unpredictable.
!

Public health relevance
To improve population health and prevent cancer and other diseases, multi-level interventions targeting underlying social, economic, and environmental conditions are necessary. This research will evaluate a method for rural population health behavior improvement, as well as provide fundamental knowledge about multi-level community systems and health behavior change.